Understanding the role of gamma oscillations underlying entorhinal cortex dysfunction in Alzheimer’s disease

Abstract
Alzheimer's disease (AD) is the most common form of dementia. It currently affects 5 million people in the US,
a number that is expected to rise to a staggering 16 million by 2050. AD not only deprives patients of their
basic mental functions, but severely batters families and caregivers. Its costs are currently estimated at $236
billion, and will likely increase to more than $1 trillion by 2050. As our society rapidly ages, the need for
combating AD is pressing. Histological and imaging studies in AD patients and animal models have shown that
the entorhinal cortex is a primary site of atrophy and activity loss in the early phases of AD. However, it is still
largely unclear what type of activity is lost in the entorhinal cortex in early AD. Using in vivo neurophysiological
recording methods, we recently demonstrated that gamma oscillations, a network activity reflecting summed
neuronal membrane potentials, are impaired in the entorhinal cortex of an AD mouse model. Our results and
recent literature suggest a possibility that entorhinal gamma oscillations can be used for both a biomarker and
a therapeutic target of AD. Here we propose studies to investigate the role of gamma oscillations of entorhinal
cortex in memory impairments using AD mouse models. Our approach involves in vivo recording of local field
potentials (theta and gamma oscillations) and spike activity, optogenetic and chemogenetic methods, closed-
loop stimulation, cell-type specific histological analyses of neuronal loss and a novel APP knock-in mouse
model. There are three Specific Aims: (Aim 1) identify the extent and time course of entorhinal cortex (EC)
gamma impairments; (Aim 2) determine whether the reactivation of network activity using gamma stimulation
of EC attenuates or eliminates memory impairments in APP-KI mice, and (3) determine cell types that underlie
the EC gamma impairment. If successful, our studies will identify in vivo network mechanisms of memory
impairment in AD, and will help identify neuronal activities as therapeutic targets to prevent or slow the
progression of disease. Furthermore, our study will help us develop more effective and safer procedures for
deep-brain stimulation as a powerful tool to preserve or improve memory function that may eventually be used
to slow the rate of memory decline in AD patients.

Public health relevance
Project narrative This proposed research is relevant to public health because the discovery of circuit and network mechanisms underlying memory impairment is ultimately expected to increase understanding of the pathogenesis of Alzheimer’s disease. Results from this project are expected to help establish new frameworks for preserving brain network function in Alzheimer’s disease, and contribute to the part of NIH’s mission to combat Alzheimer’s disease.